Role of Frontal Cortex in Self-Control

Project Summary
Behavioral control is a fundamental component of executive control and requires the ability to suppress
actions, thoughts, and desires. Deficits in behavioral control are thought to be at the core of many public health
concerns in the United States. Nevertheless, currently little is known about the mechanisms underlying
behavioral control and what leads to failures of control. Response inhibition and self-control, two key aspects of
behavioral control, are often hypothesized to be the result of a uniform neuronal mechanism for impulse
control, but they have typically been studied independently, and it is possible that the brain contains separate
neuronal mechanisms for motor and motivational control. Neuroimaging and lesion studies in humans
have implicated a network of prefrontal regions in self-control, as well inhibitory motor control, including frontal
eye field (FEF), supplementary eye field (SEF), pre-supplementary motor area (preSMA), dorsolateral
prefrontal cortex (DLPFC), and ventrolateral prefrontal cortex (VLPFC). However, it is not clear if the neuronal
circuits of motor control and self-control are identical or separate. In our proposed experiments, we will
investigate prefrontal mechanisms for self-control and response inhibition in these areas. Comparing the
mechanisms for both types of control requires tasks that allow identification of signals involved in response
inhibition and self-control. We will train monkeys both in a novel self-control task developed by us (requiring
motivational control) and in the classic stop signal task (requiring motor control). This will allow us to identify
circuit level mechanisms of self-control and response inhibition. Our Aim 1 is to determine if the neural
mechanisms of response inhibition and self-control in prefrontal cortex are shared or distinct. We will
record the neural activity of multiple neurons in FEF, SEF, preSMA, DLPFC and VLPFC. By testing identical
sets of prefrontal neurons in both tasks, we will identify neuronal activity underlying each control mechanism
and determine if identical or separate circuits are responsible for both forms of executive control. Our Aim 2 is
to determine if different areas in prefrontal cortex causally contribute to response inhibition and self-
control. Preliminary data show that inactivation of SEF by cooling will bias behavioral outcomes toward
failures of self-control. This indicates a causal role of SEF in self-control. We will systematically test the causal
role of FEF, SEF, preSMA, DLPFC and VLPFC in response inhibition and self-control, by inactivating each of
these areas and observe behavior in the delayed gratification and stop signal tasks. Inactivating one area,
while simultaneous recording in other areas will determine if neuronal representations of response inhibition or
self-control are causally dependent on activity in other parts of the network of prefrontal regions.

Public health relevance
Project Narrative The long-term goal of this research project is to understand the neural mechanisms underlying the control of behavior in two domains: self-control (motivation) and response inhibition (motor). We will record neurons from 5 different areas in the prefrontal cortex, while NHPs engage in two oculomotor decision tasks that require them to exert self-control and motor-control, respectively. This will allow us to determine the functional overlap and separation between these control systems.